Confocal video-mosaicking microscopy to guide surgery of superficially spreading skin cancers

Superficially spreading types of skin cancers such as lentigo maligna melanomas (LMMs) and non-melanoma
skin cancers (NMSCs) occur mostly on older patients, with diffuse sub-clinical sub-surface spread over large
areas and with poorly defined margins that are difficult to detect. To treat these cancers, dermatologists rou-
tinely perform a large number of mapping biopsies to determine the spread and margins, followed by surgical
excision with wide "safety" margins. Not surprisingly, such a "blind" approach results in under-sampling of the
margins, over-sampling of normal skin, too many false positives and false negatives, and too much loss of
normal skin tissue. What may help address this problem is reflectance confocal microscopy (RCM) imaging to
noninvasively delineate margins, directly on patients. RCM imaging detects skin cancers in vivo with sensitivity
of 85-95% and specificity 80-70%. In 2016, the Centers for Medicare and Medicaid Services granted reim-
bursement codes for RCM imaging of skin. RCM imaging is now being increasingly used to noninvasively
guide diagnosis, sparing patients from unnecessary biopsies of benign lesions. While the two-decade effort
leading to the granting of these codes was focused on imaging-guided diagnosis, emerging applications are in
imaging to guide therapy. We propose to create an approach called RCM video-mosaicking, to noninvasively
map skin cancer margins over large areas on patients, with increased sampling, accuracy and sparing of nor-
mal tissue. The innovation will be in designing a highly robust (against tissue warping and motion artifacts)
and high speed (real-time, seconds) approach for RCM video-mosaicking: we will develop an optical flow ap-
proach with a novel hybrid 3-stage deep learning network comprising of 8 parameters that will model global
and local rigid and non-rigid tissue motion dynamics, learn and adapt to variable tissue and speckle noise con-
ditions in patients, and predict and automatically detect motion blur artifacts. As required by PAR-18-009, our
academic-industrial partnership will deliver RCM video-mosaicking to clinicians for real-time implementation at
the bedside (translational novelty). Our proposed application is for guiding surgical excision, but the approach
will have wider impact, for guiding new and emerging less invasive non-surgical treatments for superficial skin
cancers. In a preliminary study, we demonstrated RCM video-mosaicking with real-time speed (125 millisec-
onds per frame, 8 frames per second), and registration errors of 1.02 ± 1.3 pixels relative to field-of-view of
1000 x 1000 pixels. Our specific aims are (1) to develop a real-time and robust RCM video-mosaicking ap-
proach and incorporate into a handheld confocal microscope for use at the bedside, (2) to test the approach for
image quality and clinical acceptability, and (3) to prospectively test on 100 patients, with pre-surgical video-
mosaicking of LMM margins and superficial NMSC margins, followed by validation against post-surgical pa-
thology. We are a highly synergistic team from Memorial Sloan Kettering Cancer Center, Northeastern Uni-
versity, and Caliber Imaging and Diagnostics (formerly, Lucid Inc.), with a 13-year record of collaboration.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Reflectance confocal microscopy (RCM) imaging can noninvasively diagnose skin cancers, and spare patients from biopsies of benign skin conditions. We propose to develop an approach to noninvasively delineate skin cancer margins, to help guide less invasive surgery, and help more accurately and completely remove cancer while preserving more of the surrounding normal skin.